The Regulation of Ovarian Aging by H19 and let-7

PROJECT SUMMARY/ABSTRACT
The mean age of first-time mothers is on the rise, with serious consequences for maternal health and that of
their offspring. Older maternal age is strongly associated with birth defects, miscarriage, and infertility. These
poor reproductive outcomes can frequently be traced back to defects in follicular and oocyte quantity and quality
that occur with ovarian aging. A continuous decline in the quantity of ovarian follicles (i.e. the “ovarian reserve”)
occurs during reproductive aging, as the pool of primordial follicles is continuously depleted. Additionally, oocyte
quality declines as follicles and oocytes accumulate DNA damage over time, a process which accelerates even
more rapidly when the ovary is exposed to gonadotoxins. There is therefore an urgent need to better understand
the mechanisms that control follicular and oocyte quantity and quality in order to support the health of women
and their children. The noncoding RNAs H19 and let-7 play essential roles in mammalian development, but little
is known about their role in ovarian follicle growth and oocyte function. We have uncovered a plausible
mechanism for noncoding-RNA-based regulation of follicular health via the H19/let-7 pair. We previously showed
that H19 binds and antagonizes the miRNA let-7. We also demonstrated that in the absence of H19, ovarian
AMH expression is decreased, follicular recruitment is accelerated, and fertility is compromised. We have
observed that AMH has a functional let-7 binding site, suggesting a ncRNA-mediated mechanism for AMH
regulation by H19 via let-7. Moreover, our preliminary data suggests altered response to DNA damage in the
absence of H19. Thus, there is plausible mechanistic insight into, and strong support for, the role of H19 and let-
7 in the regulation of follicular/oocyte recruitment and function. In Aim 1, we will determine the role of H19 in E2-
and AMH-mediated regulation of follicle quantity. In Aim 2, we will determine whether ovaries of H19KO mice
are more susceptible to DNA damage than their WT counterparts. Lastly, for Aim 3, we will determine whether
the abnormal follicular development and expression of DNA damage genes observed in H19KO mice is
mediated via let-7 and identify changes in the transcriptome of somatic cells and oocytes related to loss of
H19. Our approach is innovative because it represents a substantive departure from the status quo by
defining noncoding RNAs (ncRNAs) as major regulators of oocyte quantity and quality, and has the potential to
lead to novel, ncRNA-based treatments for a broad range of reproductive disease states.

Public health relevance
PROJECT NARRATIVE Reproductive health issues as serious as miscarriage, birth defects, and the loss of fertility due to advancing age or exposure to gonadotoxic agents can frequently be traced back to a decline in oocyte quality and/or quantity. We have discovered that the noncoding RNAs H19 and let-7 regulate genes involved in follicular recruitment and DNA repair, processes whose regulation is essential for the maintenance and growth of an adequate population of healthy oocytes. Our proposed studies have the potential to define noncoding RNAs as major regulators of ovarian reserve, and are directly related to the NIH Fertility and Infertility Branch’s mission of supporting research that enhances our understanding of normal reproduction and reproductive pathophysiology.